Structural investigations into the regulatory states of human Ribonucleotide Reductase

PROJECT SUMMARY/ABSTRACT
Maintaining the equilibrium of the various ribonucleoside and deoxyribonucleoside triphosphates (NTPs and
dNTPs) within cells is critical for homeostasis. As the only de novo mechanism for dNTP synthesis,
ribonucleotide reductases (RNRs) are essential enzymes in all forms of life. These metalloenzymes catalyze
the reduction of ribonucleotides into deoxyribonucleotides, which is essential for maintaining the dNTP pools
for DNA synthesis and repair. Dysregulation of RNR activity is associated with tumorigenesis, and cancer cells
are overly reliant on the enzyme as a result of their rampant proliferation. Therefore, inhibitors of RNR proteins
are effective anti-cancer therapeutics and have been proposed as potential antibiotics. However, to date, there
is no structure of human RNR in the active state, and many aspects of the protein’s regulation are still
unknown. Recent structural work on RNR proteins has resulted in high-resolution structures of the active
complex of the E. coli enzyme, which is a class Ia RNR like the human enzyme. These enzymes consist of two
dimeric subunits referred to as α2 and β2. Although these enzymes are similar, there are also significant
differences between the species. For example, while both proteins form rings when inactivated, the content of
these rings are different, and preliminary data indicates that the inactivation mechanism is also distinct. The
goal of this project is to use cryogenic electron microscopy (cryo-EM) to determine structures of the human
RNR protein in both active and inactive states. My first aim is to determine cryo-EM structures of the α2 subunit
bound to both ATP and dATP in the allosteric activity effector pocket within the regulatory domain. These data
will reveal any conformational changes of the regulatory domain due to the differential binding and ATP and
dATP that could not be observed in the crystal structures due to lattice contacts. I will then determine the
structure of the human enzyme in the active α2β2 conformation to identify key features and interactions within
the human enzyme. Together, these structures will uncover details about this integral protein and how it
functions, which I will interrogate using site-directed mutagenesis and biochemical assays. Our findings will aid
in the development of novel RNR inhibitors for the treatment of cancer or bacterial infections. As one of the
world’s most well-renowned research institutions, MIT is an ideal environment to complete these aims. My
mentor, Dr. Catherine Drennan, is an international leader in the field of structural biology with a focus on the
study of metalloenzymes. Her mentorship will enable me to excel in my postdoctoral research and allow me to
reach my best as a scientist moving forward.

Public health relevance
PROJECT NARRATIVE Ribonucleotide reductase (RNR) is an essential metalloenzyme found in all living organisms. RNR proteins catalyze the reduction of ribonucleotides into deoxyribonucleotides which are required for DNA synthesis and repair. RNR inhibitors are used clinically for the treatment of cancer, however, our understanding of the regulatory pathways of this enzyme is still incomplete. The proposed aims will use structural biology techniques to investigate the mechanism of human RNR activity and inactivation by determining structures of the protein in multiple regulatory states.